Vitality in Infants Via Azithromycin for Neonates Trial (VIVANT)

PROJECT SUMMARY/ABSTRACT
Nearly half of child deaths occur during the neonatal period, and 80% of those occur in babies with low
birthweight. Although tremendous progress has been made towards reducing under-five mortality globally,
declines in neonatal mortality lag behind those observed in older children. Low birthweight babies are at
increased risk of poor outcomes compared to those who are term-appropriate for gestational age, including
mortality, stunting, and growth failure. Recent evidence has demonstrated that the incidence of wasting and
linear growth failure is highest between birth and 3 months of age, substantially earlier than previously thought.
Interventions are urgently needed to improve outcomes in low birthweight babies and those who are
underweight and wasted (collectively referred to as infants at risk of poor growth and development); however,
these interventions must not interfere with breastfeeding and thus some well-established interventions used to
treat or prevent malnutrition in older children cannot be considered. We recently demonstrated that biannual
mass azithromycin distribution reduces all-cause childhood mortality by approximately 25% in infants aged 1-5
months, with stronger effects seen in underweight infants. This study did not include neonates due to the risk
of infantile hypertrophic pyloric stenosis (IHPS) that has been hypothesized to be associated with macrolide
use during early infancy. Recently, our study team documented only a single case of IHPS among 21,832
neonates enrolled in a trial of azithromycin versus placebo administered to neonates aged 8-27 days for
prevention of infant mortality, documenting no major risk of IHPS associated with azithromycin. Here, we
propose an individually randomized trial to test whether oral azithromycin improves nutritional outcomes and
reduces infectious burden among neonates aged 1-27 days who are at risk of poor growth and development.
The primary outcome will be weight-for-age Z-score at 6 months of age compared between arms. We
anticipate that the results of this study will provide definitive evidence on azithromycin as an early intervention
for neonates at risk of poor growth and development, who are at the highest risk of adverse outcomes.

Public health relevance
PROJECT NARRATIVE Low birthweight infants are at the highest risk of poor outcomes, including mortality and linear and ponderal growth failure. Here, we propose a randomized placebo-controlled trial to evaluate whether oral azithromycin improves growth outcomes and reduces infectious burden among low birthweight, underweight, and/or wasted neonates (e.g., infants at risk of poor growth and development) in Burkina Faso. We anticipate that the results of this study will provide rigorous evidence of the effect of early intervention with azithromycin, which has previously been shown to reduce all-cause mortality among children under 5 in sub-Saharan Africa, for infants at risk of poor growth and development.